Elucidating the role of IRF4 in reprogramming the tumor microenvironment in follicular lymphoma

PROJECT SUMMARY/ABSTRACT
Despite a characteristic indolent course, a substantial subset of follicular lymphoma (FL) patients has an early
relapse with a poor outcome. Thus far, efforts to identify factors that predict survival have been unsuccessful.
However, we and others have demonstrated the prognostic relevance of the tumor microenvironment (TME) in
FL and provided initial evidence for the role of specific genetic alterations in shaping different environments with
highly dissimilar clinical courses. Yet, the crosstalk between malignant B cells and other immune cells of the
TME is poorly understood, as is the role of molecular alterations in modulating this interplay. This underscores
the urgent need to improve our understanding of how tumor-immune interactions may drive lymphomagenesis
and represent therapeutic vulnerabilities. Through massive genetic and transcriptomic sequencing, we found
that FL patients with increased expression of IRF4, an NF-kB target with a critical role in B cell differentiation,
display dysregulated immune signatures and an immunosuppressive TME with a poor prognosis. We
hypothesize that increased IRF4 expression disrupts the immune synapse between B cells and T follicular helper
(TFH) cells while promoting suppressive T follicular regulatory (TFR) cells, in part by preventing induction of
selection molecules such as CD40 and PDL1, and in part by rewiring cytokines release. To test our hypothesis,
we propose three specific aims. In Aim 1, we will use novel transgenic mouse models with overexpression and
deletion of irf4 to investigate whether and how IRF4 controls tumor immunity in normal and malignant B cells by
integrating single-cell transcriptional and translational (CITE-seq) analysis. In Aim 2, we will use high dimensional
cytometry (CyTOF), spatially resolved proteomics (CODEX), and CITE-seq in the same mouse models to define
the effect of B cells with different IRF4 status on TFH cells. In Aim 3, we will use single-cell transcriptomic and
proteomic tools to elucidate the role of TFR cells in response to B cells differently expressing IRF4. The findings
of all aims will be validated in human FL samples.
Building on her substantial prior laboratory and clinical experience in B cell lymphoma, Dr. Patrizia Mondello will
lead these studies under the dual mentorship of Dr. Stephen Ansell, a leader in immunotherapy and TME in
lymphoma at Mayo Clinic, and Dr. Laura Pasqualucci, a world expert in the genetics and epigenetics of B cell
lymphoma at Columbia University. Mayo Clinic offers an exceptional environment for cultivating a developing
career in translational cancer research. To achieve the long-term goal of becoming a successful independent
investigator, Dr. Mondello has developed a structured curriculum of activities aimed at broadening her knowledge
base, expanding her technical repertoire, and developing leadership skills. She has also assembled an advisory
committee of leading scientists. In completing her proposed plan with this team, Dr. Mondello will be prepared
to compete for R01 funding and to launch a translational research program studying the dysregulation and
therapeutic targeting of chromatin modifiers and transcription factors and their effect on the TME in lymphoma.

Public health relevance
PROJECT NARRATIVE A substantial subset of follicular lymphoma (FL) patients has an early relapse and a poor clinical outcome; however, little is known of the molecular mechanisms responsible for these aggressive features. We have demonstrated that the tumor microenvironment (TME) plays a key role in treatment failure and found that FLs with increased expression of IRF4 have dysregulated immune signaling, a suppressive TME, and a poor prognosis. In this project, we aim to elucidate the mechanisms by which IRF4 controls tumor immunity and define the concordant immunophenotypic changes, ultimately paving the way for novel precision therapies for this unfavorable patient population.